Function and Mechanism of the Intercalated Disc Protein XinB in Cardiomyocyte Proliferation and Cardiac Regeneration

ABSTRACT
Cardiovascular diseases remain the leading cause of death in humans, yet the molecular mechanisms
underlying these devastating conditions have not been fully elucidated. Cardiac disease is especially common
in the elderly, and as the global population ages their elevated incidence will pose a serious healthcare challenge.
An important structure in heart muscle cells is the intercalated disc (ICD), which mediates the coordination of the
cardiac syncytium. It functions by connecting neighboring cardiomyocytes, thereby maintaining the functional
integrity of this syncytium; this is crucial to the proper contraction of the heart. Although many reports
demonstrate the importance of ICDs in the organization of the myocardium, relatively little is known about how
these cell-to-cell junctions transmit information between cardiac muscle cells to modulate gene expression and
cardiac function.
The Xin-repeat containing adaptor proteins Xinα and Xinβ, also called XIRP1 and XIRP2 respectively, were
first discovered by the PI. These two proteins are located in the ICD of adult cardiomyocytes and interact with
various adherens junction proteins including N-cadherin and β-catenin, supporting an essential role for them in
the formation/maintenance of this structure. They also play important roles during early cardiac development
and in the pathogenesis of heart disease. However, the role of the Xin proteins remains poorly studied and their
specific cellular and molecular functions are largely unknown. Our recent studies of the hearts of Xin knock-out
(KO) mice have identified defects in development associated with impaired cardiomyocyte proliferation. Our
studies further demonstrated a physical and genetic interaction between Xin and NF2, a component of the
important Hippo/YAP pathway. The Hippo-YAP pathway is a highly conserved cellular regulatory network that
has been previously implicated in multiple developmental systems and disease, including the heart; however,
the mechanisms of its action remain unclear and a link to the ICD is a novel and exciting new discovery.
Therefore, we have designed two integrative Specific Aims to test the mechanism by which the ICD
protein Xin mediates cardiomyocyte proliferation, maturation, and regeneration. For the first Aim, we
will investigate the interaction between Xin and the Hippo/YAP pathway. We will study how Xin regulates YAP
activity and how the interaction between Xin and Hippo-YAP signaling regulates cardiac function and
regeneration. For the second Aim, we will study how YAP/Tead1 regulates Xin transcription and test our
hypothesis that Xin-YAP cross-regulation is crucial to cardiac gene expression and heart regeneration.
The studies proposed here will reveal novel molecular mechanisms by which the important
pathophysiological Hippo/YAP signal is modulated by the ICD protein Xin in the heart. The molecules defined
in this study will become targets for therapeutic intervention in the treatment of cardiac diseases.

Public health relevance
NARRATIVE Substantial progress has been made in the treatment of cardiovascular disease, yet it remains the leading cause of death in humans. Much of this success has resulted from the development of treatments that target the underlying genetic and molecular mechanisms responsible for these devastating conditions. The studies proposed here will identify new gene targets and pathways that can also be investigated as potential avenues for therapy in patients with cardiovascular disease.